Exoskeletons for Commercial Dungeness Crab Fishing to Reduce Musculoskeletal Injuries

Abstract
This proposed research will evaluate technology not yet used in commercial fishing with potential to improve the
health and safety of fishermen. The Dungeness crab fishery is one of the most valuable fisheries in the west
coast and suffers from a high prevalence and incident rates of both fatal and non-fatal injuries. Previous research
suggests that most injuries occur with deckhands while handling fishing gear and these tasks posed substantial
physical risks for musculoskeletal disorders (MSDs) in the low back and shoulders. Hence, interventions that
reduce such physical stress should be a critical focus in crab fishing. Passive exoskeletons have been
recognized as a potential technology solution to reduce the high physical risks in various industry. Despite the
growing body of evidence, little research has evaluated the feasibility and biomechanical effects of exoskeletons
for commercial fishing. Therefore, this proposed study will systematically evaluate exoskeletons and identify
potential barriers and opportunities associated with exoskeleton use in commercial fishing. The successful study
results will provide documented benefits/limitations and applicability of exoskeletons for commercial fishing. This
study will provide important stakeholders including exoskeleton manufacturers with critical design factors to
improve the design, usability, and applicability of exoskeletons for commercial fishing.

Public health relevance
Project Narrative This research proposal will evaluate technology (passive exoskeletons) not yet used in commercial fishing with potential to improve the health and safety of fishermen. Specifically, this research will evaluate exoskeletons as a potential ergonomics intervention in reducing musculoskeletal injury risks and identify potential barriers and safety hazards associated with exoskeleton use. Using these findings, we will provide scientific evidence on the effectiveness of the passive exoskeletons in reducing the physical risk factors and identify important barriers, opportunities, and design factors for exoskeleton use in commercial fishing.